Hematopoiesis

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Hematopoiesis, organized by Drs. Trista
North, Michael Kharas and Nina Cabezas-Wallscheid. The conference will be held in Copper, Colorado from
February 25-28, 2024.
Beyond the field’s primary focus on blood and bone marrow-related biology and disease, expanding research in
hematology has contributed to fundamental shifts in areas such as our understanding of stem cell biology and
the workings of the non-coding transcriptome and the epigenome, which have provided insights into the origins
and treatment of diseases. Further, hematological cells have served as a testing ground for technological
advancements such as therapeutic genome engineering and next-generation sequencing efforts for cancer
diagnosis. Importantly, the development of targeted small molecule therapeutics and the introduction of immune-
based cellular therapies have shown direct clinical benefits. This conference was developed to bring together
biochemists, geneticists, molecular biologists and clinicians to bridge new insights into the biological
mechanisms that control developmental hematopoiesis, hematopoietic stem cell biology and cell fate control with
the diagnosis, progression and treatment of aging, inflammatory conditions and hematologic disorders and
malignancies. This conference will highlight emerging technologies, including single cell multi-omics and imaging
approaches, which are poised to fundamentally change our understanding of blood development and
homeostasis and cellular engineering methods that have substantial potential for clinical applications. The
conference will also feature emerging discoveries, such as insights into the role of clonal hematopoiesis that
predisposes individuals to hematopoietic disease and leukemic transformation. Finally, the event will provide a
platform for investigators from across disciplines and around the globe to establish productive collaborations and
stimulate new ideas to enable substantial progress and address ongoing challenges in the hematology field.

Public health relevance
PROJECT NARRATIVE Hematopoiesis is the process by which the cellular components of the blood cells are formed, and research into these pathways has enhanced our understanding of other areas, including stem cell biology, aging, inflammation and blood cancer. Recent advances have changed the way that hematological malignancies can be targeted in the clinic using small molecule drugs, antibodies and cell-based therapies. This Keystone Symposia conference will provide a platform for basic and clinical investigators from across disciplines and around the globe to establish productive collaborations and stimulate new ideas to accelerate progress in hematology field and bring new medicines to the clinic.